CRISPR/Cas9-mediated knockouts in reconstructed human epidermis to profile skin microbiome interactions

PROJECT SUMMARY / ABSTRACT
Our goal is to enable the investigation of interactions between the skin microbiome and skin cell
populations using genetically modified 3D in vitro models. The human skin microbiome – encompassing
hundreds of bacterial and fungal species – has essential roles in maintaining skin health. Skin microbiome
dysfunction or pathobiont expansion can contribute to diverse skin infections, inflammatory disorders, and skin
cancer. It is important to identify the interactions that could go awry in skin disease and to evaluate the impact
of potential therapeutic approaches for skin diseases. However, a detailed mechanistic understanding of how
these various microbes interact with host cells to maintain skin health or promote skin disease is lacking. This
knowledge gap is exacerbated due to an inability to examine host-microbe interactions at the scale needed to
probe potentially hundreds of microbes and host genes of interest involved in these mechanisms. Here, we will
leverage 3D human reconstructed epidermis (RHE) cultures built from keratinocytes and fibroblasts in an air-
liquid interface (ALI) to develop a platform that allows us to knock out human gene function and colonize with
diverse skin microbiota. We have previously used the RHE model to examine the effects of colonization of 180
genetically diverse skin staphylococci on skin barrier and innate immunity. Using single-cell RNA-sequencing
(scRNA-seq) and spatial transcriptomics (ST), we were able to pinpoint cell-type-specific interactions in our
model. However, a major gap was the ability to interrogate host mechanisms, most effectively by gene knockout
or knockdown. Recently, we built 3D ALI cultures with CRISPR/Cas9 KOs in primary bronchial epithelial cells to
investigate the innate immune response to microbial colonization. We propose using a similar approach to build
KO keratinocytes and fibroblasts to generate multi-cell type 3D KO RHEs that will enable us to investigate skin's
host-microbiome interactions. In Aim 1, we will create 3D RHE ALI cultures with CRISPR/Cas9 knockouts (KO
RHE) in a panel of skin barrier and innate immunity genes in immortalized N/TERT keratinocytes, which we will
then colonize with commensal and pathogenic skin microbes. In Aim 2, we will add an immortalized hTERT
fibroblast layer to the KO RHE model (F-RHE) and similarly colonize with the microbial panel. We will use
immunohistochemistry, RNA-seq, scRNA-seq, and ST to characterize KO RHEs' effect on fibroblasts to pinpoint
microbial and keratinocyte-fibroblast interactions that change with KO of important skin barrier and immune
components. By developing a 3D skin KO model coupled with a cutting-edge `omics approach, this proof-of-
principle study will enable the construction of large-scale, high-resolution spatial and functional maps of skin
microbiome-host cell interactions. Given the extensive biodiversity of the human skin microbiome, this platform
will be valuable for deconstructing and pinpointing interactions that could be disrupted in skin disease and for
evaluating the impact of potential therapeutic approaches for skin diseases.

Public health relevance
PROJECT NARRATIVE / RELEVANCE TO PUBLIC HEALTH The numerous bacteria, fungi, and viruses that inhabit our skin play key roles in skin health, but we need a better understanding of how these microbes interact with skin cells. To enable a detailed investigation of microbe–skin cell interactions and their effects on skin health, we seek to develop a platform for microbial colonization of cultured skin tissue that can be genetically modified to investigate host mechanisms. These technologies will enable biomedical researchers to determine how microbe–skin cell interactions impact skin barrier functions, immunity, and susceptibility to diseases arising from microbial infection.